Analysis of modulation of the metabotropic glutamate receptor type 5 in a novel heritable model of drug abuse vulnerability

Project Summary
Schizophrenia is a debilitating mental illness affecting an estimated 1% of the global population.
Substance abuse comorbidity is common in a number of mental illnesses, including post-traumatic stress
disorder, bipolar disorder, and schizophrenia, with nicotine being the most commonly abused substance. This
comorbidity has several detrimental effects, including reduced quality of life and reduced efficacy of treatment.
My lab is therefore interested in developing pharmacological interventions to reduce the rewarding effects of
nicotine and alleviate deficits in endophenotypic markers of psychosis. Previously published work in our
laboratory has established that rats neonatally treated with the dopamine D2-like receptor (DAD2) agonist
quinpirole for the first 21 days of life show lifelong increases in DAD2 receptor sensitivity, displaying a number of
behavioral phenotypes of relevance to substance abuse comorbidity in psychosis, including enhanced nicotine
conditioned place preference and deficits in sensorimotor gating. Our lab has more recently developed a
heritable model of drug abuse vulnerability in psychosis by breeding rats neonatally treated with quinpirole (NQ)
to either another NQ or a saline (NS) treated animal to produce a subsequent F1 generation. This F1 generation
displays increased dopamine signaling comparable to NQ animals in the F0 generation.
DAD2 receptors have been found to form a functionally distinct heteroreceptor complex with the
metabotropic glutamate type 5 (mGlu5) receptor, such that stimulation of mGlu5 results in reduced DAD2 affinity.
In specific aim 1, I will outline predoctoral work that has been completed which has shown that treatment
with the positive allosteric modulator of the mGlu5 receptor 3-Cyano-N-(1,3-diphenyl-1H-pyrazol-5-yl)benzamide
(CDPPB) reduces the associative rewarding properties of nicotine and alleviates deficits in sensorimotor gating
in F1 generation animals, suggesting this therapeutic agent may be a promising target for the dual treatment of
tobacco use disorder and psychosis. In the F99-phase of this proposal, I will establish the therapeutic efficacy
of CDPPB in preventing relapse-like behavior in a system sensitized to dopamine using optogenetic tools to
manipulate dopaminergic signaling in the brain reward pathway. Changes in subcellular localization of dopamine
signaling markers following administration of CDPPB will be analyzed using subcellular fractionation to determine
mechanism of action of CDPPB. Further, mechanisms of heritability conferring enhanced DAD2 sensitivity in the
F1 generation will be assessed using next generation RNA sequencing techniques. In specific aim 2, I will seek
a postdoctoral position with a strong mentoring team that will allow me to expand my training to include
use of neural recording and imaging techniques to analyze how changes on a cellular level translate to
observable changes in behavior that may contribute to the development of neuropsychiatric conditions during
the K00 phase of this proposal.

Public health relevance
Project Narrative Development of novel treatment targets for psychosis and comorbid substance use disorders are paramount, as high rates of comorbid tobacco use in psychotic disorders is known to have detrimental effects on treatment outcomes. The goal of this project is to establish the positive allosteric modulator CDPPB as a novel pharmacological intervention for the dual treatment of psychosis and comorbid tobacco use to improve treatment efficacy and overall quality of life for individuals suffering with psychosis. As a member of an underrepresented group in neuroscience, the proposed project will provide exceptional training to a postdoctoral student who is highly motivated to pursue a promising career as an independent researcher.